The Hypothalamic Basis of Aging

ABSTRACT/SUMMARY
Aging is multifaceted while many hormonal and metabolic regulators are crucial, pointing to the extremely
strong significance of endocrine and metabolic processes in aging physiology and intervention. The
hypothalamus is the “headquarters” for regulating systemic endocrine systems and metabolic physiology as
well as the autonomic nervous system for physiological homeostasis. In the past, the lab of the PI has
developed a major research area of studying the significance of hypothalamus in aging, including formulation of
the “hypothalamic control of aging” paradigm which subsequently led to the generation of anti-aging model by
hypothalamic stem/progenitor cells. The long-term objective of this research is to study the underlying
hypothalamic anti-aging basis and therefore to develop novel and effective targets for counteracting against
aging-related neurodegeneration and disease. In preliminary studies of this project, it was found that
hypothalamic extracellular vesicles (EVs) are strongly anti-aging and anti-neurodegenerative in multiple
experimental models. Also, parathymosin in these EVs was found crucial for the anti-neurodegenerative
actions in recipient neurons. Thus, this project is proposed based on the hypothesis that hypothalamic EVs are
important for brain transfer and neuroprotective while restoring these EVs has a significant interventional value
against aging-related neurodegeneration and disorders. Three specific aims are: (1) study hypothalamic and
brain transfer of hypothalamic EVs and aging relevance; (2) study the neuroprotective and anti-
neurodegenerative actions of parathymosin-containing hypothalamic EVs and the underlying basis; (3) study
the significance of hypothalamic EVs for treating neurodegenerative disorders and improving aging physiology
and healthspan. Experiments in these Aims will be carried out by using mouse models of hypothalamic
regional and cell-specific manipulations of EVs as well as models of pharmacological intervention with
hypothalamic EVs. A list of molecular, cellular and physiological methods will be used to analyze hypothalamic
EVs in terms of biochemical profile of brain distribution and uptake, the cellular effects for neuroprotection in
recipient neurons, and anti-aging physiological and therapeutic effects in relevant aging models. Overall,
successful completion of this project will lead to new important knowledge about the hypothalamic basis of
aging and novel strategy for managing healthy aging and alleviating aging-related disorders and diseases.

Public health relevance
NARRATIVE The hypothalamus plays a fundamental role in whole-body aging, but the underlying basis and the interventional value remain to be established; thus, this project is to study the aging relevance and anti- neurodegenerative actions as well as the therapeutic significance of hypothalamic extracellular vesicles. Overall, the study represents a major milestone for developing an important strategy and target for aging- associated health problems and especially neurodegeneration and related diseases.